HIV vaccine swarms for PWID

PROJECT SUMMARY/ABSTRACT:
More than 80 million people have become infected with HIV since the start of the epidemic, and people who
inject drugs (PWID) are particularly affected by this disease. Developing an HIV vaccine has been challenging
in great part because of the high variability of HIV. Thus, we propose that an effective HIV vaccine would need
to encode diverse antigens to capture the natural sequence diversity of HIV exposures. During mucosal
transmission, the mucosa can offer partial protection against HIV by acting as a natural barrier, reducing the
number of founder viruses that can cause infection. In contrast, during intravenous transmission, the virus enters
directly into the circulation without any mucosal protection, leading to infection by many viral quasispecies.
Therefore, developing a vaccine to prevent intravenous HIV transmission is strikingly more difficult. For an HIV
vaccine to protect PWID against intravenous transmission, it would need to elicit high levels of immune
responses to rapidly clear the multiple viral strains that are injected after needle use.
Here, we will develop novel polyvalent vaccines encoding highly diverse HIV envelope sequences, derived from
HIV+ PWID. In addition, we will utilize a vaccine dose fractionation regimen that elicits 19-fold superior
neutralizing antibody responses compared to conventional vaccine regimens. We will determine whether the
vaccines expressing diverse envelope sequences confer superior protection against intravenous HIV challenges
in animal models. These studies may provide a rationale for a future clinical trial to evaluate the efficacy of
polyvalent HIV vaccines, referred to as vaccine swarms, in PWID. Taken together, our overarching hypothesis
is that HIV vaccines for PWID can be more effective by: 1) incorporating multiple antigenic sequences present
during a natural HIV infection; and, 2) utilizing a more immunogenic vaccine dose regimen. These studies can
provide a framework for developing more effective vaccines against other variable pathogens besides HIV,
including HCV, which disproportionately affects PWID.

Public health relevance
PROJECT NARRATIVE: HIV disproportionately affects people who inject drugs (PWID). We will develop vaccine libraries encoding diverse HIV sequences, and we will measure their protective efficacy against intravenous HIV challenges, using a novel vaccine fractionation approach designed to optimize immune responses.